Clinical Care Gaps and Unmet Needs in Adolescent and Young Adult (AYA) Cancers

Project Abstract
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as “NOT-CA-
24-041.” There is an urgent need to provide high-quality survivorship care to the rapidly growing population of
adolescent and young adult (AYA) cancer survivors. Approximately 90,000 AYAs are diagnosed with cancer
each year. AYAs, defined as those diagnosed between 15-39 years of age, are at unique developmental life
stages regarding their emotional, cognitive, and social development. A cancer diagnosis is highly disruptive to
completing education, establishing families, and/or starting employment. AYA cancer survivors have enduring
complex health care needs requiring coordinated care, including surveillance for cancer recurrence,
management of long-term and late effects, and appropriate preventive care. However, serious gaps in care
have been identified for AYA survivors, including underuse of National Comprehensive Cancer Network
(NCCN) guideline-recommended cancer surveillance (e.g., mammography, colonoscopy) as well as underuse
of primary care services such as vaccinations and general disease screenings. AYA survivors also experience
significant disparities in care and outcomes associated with race, ethnicity, and socioeconomic status. The new
National Standards for Cancer Survivorship Care provide a robust framework for developing and assessing
survivorship care programs across and within U.S. healthcare systems. These standards have the potential to
improve cancer survivorship care, particularly for AYA survivors given the known gaps and inequities in receipt
of NCCN recommended services for cancer surveillance and preventive care. Thus, we propose to examine
the recommended Health System Processes and Evaluations/Assessments as described in the National
Standards for Cancer Survivorship Care in a large integrated healthcare system, Kaiser Permanente (KP). The
proposed work will be a supplement to our current program grant (P01CA233432) funded through the National
Cancer Institute, “Clinical Care Gaps and Unmet Needs in Adolescent and Young Adult Cancers.” The P01
provides a robust structure for the leadership, administrative, programming, and analytic needs to evaluate the
National Standards via this Administrative Supplement. We will leverage our existing large contemporary
cohort of AYA cancer survivors cared for within KP to: 1) Examine the availability of the new National
Standards within KP; 2) Assess referral to and utilization of recommended National Standards within our KP
AYA cancer survivor cohort. We will analyze receipt of referral and utilization stratified by patient demographic
and cancer characteristics. The proposed study will be one of the first to assess availability, referral to and use
of the National Standards for Cancer Survivorship Care in a large integrated healthcare system, with a focus
on an existing diverse cohort of AYA cancer survivors. Primary findings will support future studies including
examination of the National Standards in other settings, assessment of health system survivorship policies and
related impacts, and development of targeted healthcare system interventions to address gaps in care.

Public health relevance
Project Narrative There is an urgent need to provide high-quality survivorship care to the rapidly growing population of adolescent and young adult (AYA) cancer survivors. The new National Standards for Cancer Survivorship Care provide a robust framework for developing and assessing survivorship care programs across and within U.S. healthcare systems. We will leverage our existing large contemporary cohort of AYA cancer survivors cared for within Kaiser Permanente to: 1) Examine the availability of the new National Standards within KP; 2) Assess referral to and utilization of recommended National Standards within our KP AYA cancer survivor cohort; the proposed work will be a supplement to our current program grant (P01CA233432).